Hyaluronidase mediated GBS Disease

ABSTRACT
Bacterial infections during pregnancy are a major risk factor for preterm birth (PTB), stillbirth, fetal injury and
neonatal disease. Currently, there are no preventive measures for pregnancy associated adverse outcomes or
neonatal disease due to bacterial infections. Group B Streptococci (GBS) are Gram-positive bacteria that
asymptomatically colonize the lower genital tract but can cause PTB, stillbirth, early onset disease (EOD) or late
onset disease (LOD) in human newborns. Using pregnant mice and nonhuman primates, we previously showed
that hyaluronidase (HylB)-expressing GBS infect the amniotic cavity leading to fetal bacteremia and preterm
labor. HylB breaks down host hyaluronan into immunosuppressive disaccharides, which inhibit TLR2 and TLR4
mediated proinflammatory signaling, thereby increasing the severity of GBS infections. In new studies, we show
that HylB exacerbates GBS early and late onset neonatal disease. Together, these data identify HylB as a key
virulence factor crucial for many facets of GBS disease during pregnancy and in newborns. Here, we will utilize
novel ex vivo human organotypic models and in vivo mouse models of GBS EOD and LOD using hyaluronan
receptor proficient and deficient mice to elucidate how HylB modulates immune responses for GBS neonatal
disease. We will also determine if vaccine strategies targeting HylB can diminish GBS infection mediated preterm
births and neonatal disease. These results will have broad relevance for pathogens that utilize hyaluronidase or
immune suppression for disease pathogenesis.

Public health relevance
NARRATIVE Group B Streptococcus (GBS) is an important cause of adverse pregnancy outcomes and invasive neonatal disease. Our studies have shown that the GBS hyaluronidase enzyme (HylB) is important for its ability to cause invasive infections during pregnancy. Here, we will evaluate how HylB mediates early and late onset neonatal infections using novel ex vivo and relevant in vivo models and determine if vaccine strategies targeting HylB can enhance bacterial clearance and prevent GBS infection associated preterm births and neonatal disease.